Effect of iron status trajectories on lung function and asthma risk

A2. Abstract of the Funded Parent Grant (R03HS029088)
Undertreatment of childhood asthma is prevalent and often the right treatment for incident cases is unknown hence the
widespread use of therapeutic trials as a treatment strategy. Two-thirds of incident childhood asthma cases continue to
have persistent symptoms even after treatment initiation. Missed opportunities for early efficacious treatment contribute to
increased risk of childhood asthma-associated morbidity (i.e., uncontrolled asthma) that exerts a substantial burden on
patients, families, and the healthcare system. However, clinical decision-making tools needed to identify which child will
benefit from which treatment at an early stage are currently lacking. This proposal is predicated on the notion that
applying novel machine learning (ML) methodologies to increasingly available electronic health record (EHR)
risk/prognostic data can generate predictive analytics and insights regarding childhood asthma treatment response.
Clinicians can then use such insights toward effective treatment decision-making at point of care, including more
proactive and personalized treatment, for improved patient-centered outcomes. Although risk and prognostic factors
needed for treatment response prediction are often embedded in EHR, this information is sometimes overlooked by
clinicians. In busy pediatric clinics, active EHR review to identify such factors to inform treatment decisions can be
costly, time-consuming, error-prone, and infeasible. To address these challenges and technological gap, we propose to
develop, validate, and evaluate a childhood asthma Passive Digital Marker for treatment response prediction (PDM-TR),
that is, a ML algorithm that can retrieve and synthesize pre-existing 'passively' collected mother-child dyad
risk/prognostic data in 'digital' EHR to provide an objective and quantifiable 'marker' of treatment response. We
hypothesize that when applied to risk/prognostic EHR data derived from incident asthma cases exposed to first-line
treatments, our PDM-TR will predict asthma control at 2-3 months with high accuracy (≥80 sensitivity and ≥80
specificity). The PDM-TR will 'learn from existing EHR data' to predict whether a specific treatment may be successful
(i.e., achieve asthma control) for a given individual with a specific set of attributes (i.e., asthma risk and prognostic factors
[e.g., history of allergy sensitization, eczema, demographics, lung function, body mass index]). Applying our novel PDM-
TR in-real time to readily available EHR data could contribute towards the development of a timely, accurate and scalable
approach to inform personalized childhood asthma treatment at point of care.

Public health relevance
Project Narrative Using active electronic health records (EHR), the parent grant will develop a Passive Digital Marker for the Prediction of Childhood Asthma Treatment Response to reduce errors in identifying at-risk children and can enable clinicians to scale up treatment decisions that are cost-effective, feasible, and timely. The proposed project will focus on one aspect of the parent project, i.e., adding hematologic markers, an important component of child nutrition and asthma care that may modify treatment response. The proposed project will use existing EHR data on hematologic tests and ML decision-rules- based algorithm from the parent study to assess the role of iron status on asthma treatment response.